UofL RBL BSL3 Practices and Workforce Development Core

SUMMARY: BSL-3 PRACTICES AND WORKFORCE DEVELOPMENT CORE
The BSL-3 Practices and Workforce Development Core (BSL-3 PWD) shall develop and maintain SOPs,
biosafety and biosecurity plans and provide training for BSL-3 best practices to ensure a safe and secure work
environment within the University of Louisville (UofL) Regional Biocontainment Laboratory (RBL). The BSL-3
PWD Core will support the RBL’s mission to provide a regional resource to facilitate research goals for
biodefense, emerging infectious diseases, and pandemic preparedness and response. The Core will provide
BSL-3 practices training to investigators at UofL, regional academic investigators with BSL-3 facilities, and
specialized biosafety and biocontainment professionals and tradesmen who support the operations the UofL
RBL and the RBL network. The specific aims of the BSL-3 PWD core to: (1) Provide laboratorians and personnel
training for BSL-3 best practices to ensure a safe and secure work environment within the RBL and support the
RBLs mission; (2) Develop and maintain Standard Operating Procedures (SOPs) for personnel working in the
BSL-3/ABSL-3 space in the RBL, (3) Provide select agent training for handling of select agents, inventory, and
accountability; (4) Provide Operations and Maintenance training for specialized biosafety and biocontainment
professionals and tradespeople who support the operations of the RBL; and (5) Provide biosafety education and
training for removal of materials and equipment from the BSL-3, policies for shipping and receiving materials,
and waste management.